Hypoxemia with Sleep in Sickle Cell Anemia-Prevalence, Clinical and Cellular Impact & Response to Therapy: A Multi-Site Prospective Study Accessing New Collaborative Pathways

Sickle cell disease (SCD) arises from a gain-of function mutation of hemoglobin (Hb) in which sickle
hemoglobin (HbS) polymerizes, but only after it has delivered its oxygen, and become deoxy-HbS. These
polymers wreak havoc inside the red blood cells (RBCs), resulting in rigid, adhesive, and fragile RBCs, then
anemia, inflammation, and, with time, progressive vasculopathy. SCD comprises both homozygous sickle cell
anemia (SCA, HbSS or HbSb0) and variant (HbSC or HbSb+). We will focus on SCA which is more common
and has been historically most affected by low oxygen or ‘hypoxemia’. A decreased oxygen level, measured as
a low saturation of Hb (SpO2), likely makes SCA worse due to the central role that deoxy-HbS plays in damage
from sickle cell. An association between hypoxemia during sleep and impaired brain, genitourinary, and
cardiopulmonary health has been described in children with SCA. Studies of sleep-associated hypoxemia in
adults have been less informative, likely due to the inability of even well-designed single site studies to fully
describe subtle comorbidities. In this proposal, we will examine the prevalence, impact, and response to
treatment of hypoxemia during sleep in adults with SCA, the most severe form of sickle cell disease, at 4
institutions, encompassing dense urban sites (Philadelphia, Newark) and more heterogeneous sites
(Birmingham and Chapel Hill, with significant rural outreach). This multi-site study will focus on patient reported
outcomes, a cognitive screening test, clinical co-morbidities, routine clinical labs, echocardiograms to identify
right to left shunts (which may contribute to this low oxygen), and cellular biomarkers. We want to understand
the prevalence of, and impact of treatment for, sleep hypoxemia. A secondary aim will be to identify meaningful
short term RBC and plasma biomarkers, which could be helpful in better identifying and managing this
comorbidity. Significant barriers to multi-site prospective studies in SCD include a lack of coordination amongst
centers, inconsistent and inadequate government and foundation support, and lack of access to a longitudinal
prospective national registry. (None of which are true in parallel more supported diseases such as Hemophilia
and Cystic Fibrosis). Recently, there has been a sustained effort, by affected individuals living with SCD and
their health care communities, to comprehensively address complications from SCD in the modern era. The
American Society of Hematology clinical trials network (ASH CTN), which facilitates intra-institution
coordination, and the globin research network for data and discovery (GRNDaD) registry, which streamlines
longitudinal deidentified data collection at multiple sites, are two new collaborative efforts that we are
accessing in order to lower barriers to multi-site studies in SCD. We do not have many treatments for SCD;
there is an urgent need to identify modifiable risk-factors, such as occult sleep hypoxemia, in adults. It
is possible that evaluation for sleep hypoxemia may be an important part of improved health care for
adults with SCA, and this proposal seeks to begin to answer that question.

Public health relevance
PROJECT NARRATIVE Sickle cell disease is an inherited anemia and blood vessel disease that is caused by abnormal sickle hemoglobin, and it is painful, lifelong, and life-shortening and aﬄicts 100,000 Americans. Improving health in the majority of people with sickle cell disease who are currently not able to think about the new exciCng gene therapy treatments (too ill, too old, limited resources) is a major goal of our work. Sickle cell disease is made worse when oxygen levels are low so we will screen 300 people with sickle cell disease for low oxygen levels during sleep, and we will treat those who have low oxygen levels with oxygen, and we will see if this can make a diﬀerence.